UAB Center for Precision Animal Modeling (CPAM) - Resource and Service Section

ABSTRACT (RESOURCE AND SERVICE SECTION, RSS)
The Resource and Service Section (RSS) supports CPAM and the disease research community by accelerating
the genetic, biochemical, and cellular analyses of pathogenic mechanisms of disease. The RSS accomplishes
this by providing access to rigorously controlled in vivo/in vitro models for the assessment of human disease
variants and testing of therapeutic strategies. The RSS contributes to key areas of the CPAM’s pipeline to support
the Center’s mission including Cell Line RNA Profiling, Variant Specific Assay Development; Quality Control,
Special Phenotyping, Cryopreservation, and Distribution; and Drug Toxicology and Therapeutic Screening. One
of CPAM’s strengths is the diversity of animal and cell systems that we utilize to generate models allowing
comparative analyses. The RSS will archive and distribute models created by CPAM’s Disease Modeling Unit to
outside investigators and/or NIH-sponsored national repositories. We are also a checkpoint that helps ensure
quality control, data management, data distribution, and data input for bioinformatic analyses performed by the
Bioinformatics Section and for entry into the CPAM data curation portal called Rosalution. In our pilot phase
(CPAM1.0) our emphasis was on model generation. With the renewal (CPAM2.0), we have more emphasis on
disease relevant phenotyping and therapeutics testing. Indeed, for select cases the DMU will generate patient-
specific disease variants in iPS cells matched to corresponding animal models. The RSS with the Bioinformatic
Section (BIS) will analyze transcriptional profile changes associated with the variant, predict interacting drugs,
and then rapidly begin validating and screening the iPS cells with potential therapeutics. The RSS will be poised
to compare these cell line and drug testing results directly to animal model phenotyping and therapeutics data.
The RSS is a bridge between all other components in CPAM and outside investigators to promote use of CPAM
resources. Importantly, the RSS provides access to enhanced services that are difficult to accomplish in most
individual labs and are not readily available through other mechanisms or are prohibitively costly in terms of
expense and/or time impediments. Our team is composed of animal model and drug testing experts in a variety
of areas (ciliopathies, Rasopathies, neurodevelopmental/degenerative disorders, birth defects, cancer, and
musculoskeletal/neuromuscular disorders). Hence, at a minimum, we can provide specialized services in these
broad areas leading towards both improved models that phenocopy human disease and novel therapeutics
evaluated at a fraction of traditional drug screening efforts. We facilitate high level, scientific dialogues between
CPAM and external and internal investigators and provide validated models allowing for phenotype assessment
in collaboration with the DMU and the Pre/Co-clinical Section (PCS). The goal of these conversations is to foster
new collaborations resulting in detailed secondary/advanced phenotyping through UAB Core Resource facilities
that validate variant pathogenicity (in cell or animal models), provide new biological insights, and promote
effective targeted therapeutics testing of the models generated by the CPAM pipeline.